Investigating the clinical ontologies of loss-of-function and gain-of-function human gene variants

PROJECT SUMMARY/ABSTRACT
This proposal is for an MD/PhD student’s individual pre-doctoral fellowship application. Joseph Park, the
applicant under consideration, proposes a research training plan with the long-term goal of developing into an
independent physician-scientist studying the genetic mechanisms underlying cardiometabolic and other
complex diseases using computational, experimental, and translational approaches. Genome-wide association
studies (GWAS) have successfully described the roles of common genetic variation on human diseases by
analyzing large populations with shared disease traits, but the clinical ontologies of numerous genes remain
incompletely described through these phenotype-based methodologies. Additionally, a fundamental problem of
genetic association studies remains to be the difficulty of describing the functional consequences of disease-
associated variants to their respective gene products (i.e. loss- vs. gain-of-function). The Penn Medicine
Biobank, a healthcare system-based database of genotype, whole-exome sequencing, and electronic health
record (EHR) data, allows for an unbiased, genotype-first approach to describing the relationships between
dysfunctional genes and human disease traits captured in the clinical setting through phenome-wide
association studies (PheWAS). Through gene-burden PheWAS tests, the proposed study aims to characterize
the clinical manifestations of disease caused by rare, loss-of-function mutations in each gene on a genome-
wide scale. Our analyses will enable clinicians to more effectively identify genetic diseases among their
patients in the clinical setting. Furthermore, in addition to our interrogation of loss-of-function mutations, our
proposed project has the potential to define the roles of known gain-of-function mutations in human disease
and identify novel gain-of-function variants relevant to disease, offering a direction for investigators to design
follow-up experimental studies in the basic sciences as well as a platform promoting more efficient therapeutic
discoveries. And importantly, while conducting the proposed study, Joseph will receive rigorous training in
computational biology and statistical genetics during the funding period, promoting his maturation into a
successful, independent physician-scientist thoroughly prepared for a clinical career involving the analysis of
“omics” and “big data”. These goals will be accomplished through the extensive fellowship training plan jointly
developed by him and his sponsor, Daniel Rader. Through the mentorship of numerous senior investigators,
regular attendance at seminars, conferences, and other opportunities for presentation and interaction with
renowned scientists at the University of Pennsylvania, and the collaborative research environment that the
Rader laboratory and its physically surrounding organizations promote, Joseph is well-equipped to achieve his
career goals through his guaranteed development during the proposed training.

Public health relevance
PROJECT NARRATIVE Genome-wide association studies (GWAS) have successfully described the roles of many human genes by analyzing large populations with shared traits, but these phenotype-based methodologies have incompletely described the clinical implications of numerous genes. I propose to address this knowledge gap by taking an unbiased, genotype-first approach to describing the relationships between dysfunctional genes and human disease traits through gene-burden phenome-wide association studies (PheWAS), essentially intersecting data from our healthcare system-based biobank database comprised of genotype data, whole-exome sequencing, and electronic health records (EHR). In addition to capturing the disease implications of rare, loss-of-function mutations on a genome-wide scale, my proposed project has the potential to define the roles of known and novel gain-of-function mutations in human disease, offering a direction for follow-up functional studies as well as a platform for more efficient therapeutic discoveries.